Linking actin cytoskeleton to membrane dynamics in mitochondrial fission - Undergrad Supplement

Abstract
Not required per the FOA.

Public health relevance
Project Narrative We are discovering novel functions for actin cytoskeleton in organelle dynamics, with one focus being mitochondrial fission. This work has direct impact on two human diseases: focal segmental glomerulosclerosis (kidney) and Charcot-Marie-Tooth disease (a neuropathy). It also impacts major neurodegenerative diseases (Alzheimer's, Parkinson's and others).